Investigating the Formation and Remodeling of Uterine Spiral Arteries during Pregnancy

Project Summary
Proper uterine vascularization is critical for a healthy pregnancy. Abnormalities in uterine vascular density are
associated with infertility. Moreover, incomplete remodeling of the spiral arteries (SAs), vessels which transport
maternal blood into the placenta for maternal-fetal nutrient exchange, is associated with the hypertensive
disorder preeclampsia. Although uterine blood vessels, especially SAs, play an essential role in supporting
pregnancy, little is known about how these vessels develop and remodel. The objectives of this proposal are
therefore to 1) characterize the formation of SAs on a cellular and transcriptional level, and 2) define the
molecular mechanisms underlying SA remodeling. While it is known that SAs are present in the uterus by mid-
gestation, a mechanism for their formation has not been previously proposed. Our preliminary data indicate
that SAs do not form via vasculogenesis or arterial sprouting, two common mechanisms by which new arteries
develop. Thus, we hypothesize that SAs form via an alternative mechanism: angiogenesis from uterine veins.
In Aim 1, we will rigorously test this hypothesis using light sheet imaging, lineage tracing, and single nucleus
RNA sequencing. Additionally, we have detected high expression of the vascular remodeling protein
Angiopoietin 2 (ANG-2) in the uterus during pregnancy. ANG-2 destabilizes blood vessels in a number of
developmental and pathologic contexts by promoting the dissociation of smooth muscle cells from endothelial
cells. In the uterus, the loss of smooth muscle cells from SAs appears to initiate SA remodeling. We
hypothesize that ANG-2 is required for this process. In Aim 2, we will use pharmacologic and genetic methods
to investigate how loss of ANG-2 signaling affects SA remodeling and pregnancy outcomes. Together, these
studies will bring novel insights into the mechanisms by which blood vessels form and remodel in the uterus,
which could have important implications for our understanding of infertility, preeclampsia, and other vascular
complications of pregnancy.

Public health relevance
Project Narrative Spiral arteries are dynamic uterine vessels that carry maternal blood into the placenta to facilitate efficient nutrient exchange between mother and fetus. These vessels are critical for supporting a healthy pregnancy, however the mechanisms underlying their development and remodeling are poorly understood. The proposed studies will characterize the formation of spiral arteries on a cellular and transcriptional level and investigate the role of Angiopoietin 2 signaling in spiral artery remodeling.